Efficacy of a self-advocacy serious game intervention for women with advanced cancer

Project Summary
Individuals with cancer must overcome multiple, ongoing challenges (“self-advocate”) related to their cancer
experience to receive patient-centered care. Women with metastatic breast or advanced gynecologic cancer
often face significant challenges managing their quality of life concerns and cancer- and treatment-related
symptoms. If they do not self-advocate to manage these concerns, they risk having poor quality of life, high
symptom burden, and care that is not patient-centered. Serious games (video games that teach) are effective
health interventions that allow users to vicariously engage in situations reflecting their personal experiences,
receive meaningful information, and learn personally relevant skills that they can apply in real life. The long-
term objective of this work is to prepare patients with cancer to engage in patient-centered care by teaching
them self-advocacy skills using immersive, accessible technologies. The goal of the current study is to test the
efficacy of a novel intervention using a serious game platform to teach self-advocacy skills to women with
metastatic breast or advanced gynecologic cancer. The Strong Together intervention consists of a multi-
session, interactive serious game application with tailored self-advocacy goal-setting and training. The serious
game is based on a self-advocacy conceptual framework and applies behavior change theories and serious
game mechanisms to promote skill development and implementation. The game works by immersing users in
the experiences of characters who are women with advanced cancer; requiring users to make decisions about
how the characters self-advocate; demonstrating the positive and negative consequences of self-advocating or
not, respectively; and providing multiple, individualized feedback mechanisms and game features to enforce
self-advocacy skill acquisition and transference to real life. This study evaluates the efficacy of the Strong
Together intervention by conducting a randomized clinical trial in 336 adult (ages >18 years) women within
three months of a metastatic breast or Stage III or IV gynecologic cancer diagnosis. Participants will be
randomly assigned to receive the 3-month Strong Together intervention or a paper self-advocacy guide. The
primary outcome is patient self-advocacy. Secondary outcomes include quality of life, symptom burden, and
patient-centered care. The central hypothesis is that the experimental group will have higher self-advocacy,
quality of life, and patient-centered care and lower symptom burden compared to the paper self-advocacy
guide group. As an exploratory outcome, we will determine if the intervention reduces suboptimal healthcare
utilization. The study will also evaluate the behavioral and game mechanisms that influence the efficacy of the
Strong Together intervention. This study provides the first theoretically based self-advocacy intervention for
adult women with cancer and clarifies the mechanisms by which serious games teach skills and assist in
transferring those skills to real life. Self-advocacy interventions have the potential to advance patient-centered
care by providing patients with tangible skills that prepare them to meaningful engage in their cancer care.

Public health relevance
Project Narrative The proposed study addresses the following public health problems among women with advanced cancer: (1) lack of skills training to equip patients with the skills necessary to engage in patient-centered care (“self- advocacy”), (2) declines in quality of life and high rates of cancer- and treatment-related symptom burden, and (3) fragmented healthcare systems that place the burden on patients to navigate their care proactively. Healthcare clinicians should be concerned about patients who cannot self-advocate because these patients cannot effectively participate in their care and experience worse health outcomes compared to patients who can self-advocate. It is imperative to equip patients with self-advocacy skills so that they can address the challenges associated with advanced cancer (e.g., complex treatment decisions, difficulty communicating with healthcare providers, and barriers to managing social support) and ensure they receive care that reflects their values, preferences, and beliefs.